Understanding the Cognitive Neural Signatures of Childhood Maltreatment in Adolescents as a Means to Advance the Science of Targeted Academic Intervention to this Vulnerable Population

The K01 proposal seeks to provide an early career educational neuroscientist (Dr. Suzanne Perkins) with the
training, mentorship, and resources to fill the gap in the need for translational and transdisciplinary researchers
in childhood maltreatment (CM) who can navigate between neuroscience and social welfare to bring needed
intervention to this population. This award will provide the necessary support to launch her independent
scientific career focused on CM using advanced neuroscience methods to delineate cognitive developmental
neural mechanisms for children that experience childhood maltreatment leading to cognitive functioning
deficits. The candidate's scientific goal is to define the brain basis of adverse cognitive consequences of CM,
refine a mechanistic theory, and develop mechanism-targeted interventions for early preventative care for this
population. Although there has been great progress in understanding the role of early life adversities (ELA) on
the development of psychopathology, there is limited research on behavioral and neuroscience models of
academic deficits in this population. In the proposed project, the candidate will harness her expertise as a
former special educator to identify CM neural patterns in a large adolescent sample of normative development
(ABCD) and a newly acquired substantiated CM sample, develop best practices neuroscience methods for
smaller CM-specific cohorts, test a mechanistic theory, and work with community partners toward the
development of intervention. To examine the proposed neurobiological model of CM, a series of multivariate
predictive models of resting-state and task-based measures of cognition will be conducted using Brain Basis
Set (BBS) modeling with principal component reduced data and a leave-one-site-out cross-validation
framework. The candidate aims to 1) develop transdisciplinary and data-driven approaches to the
identification of CM cohorts in a large cognitive developmental dataset (ABCD), 2) distinguish
cognitive neurobiological models of CM using the cohorts derived in phase 1 of adolescents with CM
from ABCD and 3) Adjust Phase 2 derived predictive models to a pilot sample of adolescents with
substantiated CM (n = 60) and matched controls (n = 60) to accurately model the complex
characteristics of CM. Finally use derived models as pilot data in subsequent R-level awards. Dr.
Perkins will complete the following training objectives: 1) Train in translational and transdisciplinary CM
science, 2) gain expertise in developing machine learning (ML) brain-wide networks in theoretical and
data-derived CM cohorts and translation of those networks to smaller CM cohorts, and 3) Gain
expertise in working with community partners. The proposed K01 aims and objectives will ensure that Dr.
Perkins is positioned for an independent scientific career in translating neurocognitive science to social welfare
intervention and developing educational early interventions to target disrupted neural function. This will set the
candidate up to fill a gap in CM researchers bridging disciplinary gaps that hamper intervention development.

Public health relevance
Childhood maltreatment is a significant worldwide public health problem, experienced by approximately ⅓ of all children and costing the US approximately $2 trillion during the lifetimes of a one-year cohort of children. Children with maltreatment histories are known to suffer long- term negative academic outcomes that result in a loss of income and career attainment for those affected. The brain basis of the adverse cognitive consequences of child maltreatment is not well understood and this project will fill this gap so that targeted academic interventions can be developed and implemented.